Cancer Pharmacokinetics Research Specialist

Summary
The long-term goal of this application is to provide stable research funding for a Cancer Pharmacokinetics
Research Specialist within the UPMC Hillman Cancer Center (HCC) Cancer Pharmacokinetics and
Pharmacodynamics Facility (CPPF).
The activities of the Cancer Pharmacokinetics Research Specialist can be categorized broadly into: (1)
Preclinical cancer research; and (2) Clinical cancer research. The Cancer Pharmacokinetics Research
Specialist plays an absolutely critical role in developing and validating novel LC-MS/MS methodologies, and
applying them to precisely delineate the PK and metabolism of novel and established agents.
The Research Specialist's career goals are to expand his armamentarium by completing the CPPF
instrument upgrade; to expand his skill-set by taking training and courses on the new instruments and software
and cross-train CPPF personnel; thereby maximizing utilization of novel instruments, which is sure to enhance
the research output of the CPPF. This award will allow the CPPF Cancer Pharmacokinetics Research
Specialist to continue to be at the cutting edge, with the ultimate aim of serving the scientific community in
early drug development needs.

Public health relevance
Project Narrative The Cancer Pharmacokinetics Research Specialist will support the development of new anticancer agents through supporting preclinical and clinical cancer research, thus serving the scientific community in early drug development needs which will lead to enhancement of patient care and treatment outcome.